A PULSED CONDENSATION PARTICLE COUNTER FOR COST EFFECTIVE MONITORING OF ULTRAFINE AIRBORNE PARTICLES

A PULSED CONDENSATION PARTICLE COUNTER FOR
COST EFFECTIVE MONITORING OF ULTRAFINE AIRBORNE PARTICLES
ABSTRACT
This project will develop and validate a new approach for affordably monitoring the number concentration of
ultrafine airborne particles. Ultrafine particles are specifically implicated in health, and yet are not detected by
lower-cost sensors. Our approach is a Pulsed Condensation Particle Counter that uses adiabatic expansion
combined with single particle counting. Our Phase I results demonstrate that this approach is reliable over
months of continuous operation, with ±10% agreement with expensive, research-grade condensation particle
counters. Our target is an affordable portable instrument, priced at a fraction of the cost of current instruments,
that measures the particle number concentration with known accuracy and precision. The envisioned
commercial instrument will include a commercial optical counter and report ultrafine particle number
concentration and estimated PM2.5 mass.
This Phase II project will improve the performance of the Phase I system, refine the supporting components,
and integrate the electronics and components into a compact system. The complete prototype system will be
tested under both laboratory and field conditions. Instrument precision and accuracy over a range of particle
sizes and concentrations will be evaluated with monodispersed, laboratory aerosols, using particle sizes
ranging from 5 nm to 2500 nm, and concentrations from near zero to several hundred thousand per cubic
centimeter. Instrument robustness will be evaluated through stress-testing at extremes in temperature (5°-
40°C) and humidity (5%-95%). Monitoring performance and stability will be tested through comparison with
collocated benchtop instruments over weeks of unattended operation. Measurements under field conditions
will be conducted in collaboration with a local university exposure study. Validation as a monitor will be done in
collaboration with an air monitoring district. The objective is a compact, cost-effective monitor with a particle
detection limit below 5 nm, with precision of ±10% for concentrations between 10 - 104/cm3, and precision of at
least ±15% for concentrations reaching 105/cm3, and data recovery of at least 90%.

Public health relevance
NARRATIVE Ultrafine particles are ubiquitous in urban air and are known to be associated with adverse health risks, yet there are no suitable tools for widespread monitoring of their concentrations. This project will develop a new, compact low-cost monitor to measure the number concentration of these airborne particles. Based on fundamental principles rather than heuristic correlations, this instrument will provide data of known accuracy and precision. It will be suitable for indoor monitoring in schools, offices, care facilities and industrial environments, and will meet many of the needs for distributed network monitoring.